THE MTUBERCULOSIS PROTEOME INTERACTION MAP (IMAP) DURING PERSISTENCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The aim is to generate a protein interaction map for M.tuberculosis in the persistent state. There is great potential that this information will accelerate the identification and prioritization of drug targets for antibiotics that kill persistent M.tuberculosis. Proteins will be tagged in M.tuberculosis strains grown in the lab of Prof. Jeffrey Cox, purified using affinity chromatography, and identified by MALDI-TOF and LC/MS/MS mass spectrometry. Initially, approximately 20 proteins will be purified from log phase cultures, and ultimately the project aims to purify approximately 200 proteins from persistent M.tuberculosis cultures, with mass spectrometry analysis carried out on the successful purifications, to generate a physical interaction map for the persistence regulon.